Adaptation of a synapse-specific version of GFP Reconstitution Across Synaptic Pa

DESCRIPTION (provided by applicant): Understanding how organisms extract sensory information from their environment, encode it into electrical and chemical signals, then integrate and process these signals to produce behavioral responses conducive to survival, is a fundamental goal of neuroscience. A prerequisite for understanding how any given behavior is generated is knowledge of both the identities of the component neurons of the underlying neural circuit and the synaptic connectivity relationships among them. In this application it is proposed to adapt to Drosophila the second-generation GFP Reconstitution Across Synaptic Partners (GRASP) technique recently developed in the mouse. Unlike the original version of GRASP that had a high false-positive rate, this improved version of GRASP produces GFP signals exclusively at synaptic contact sites. Adaptation of this synapse-specific version of GRASP to Drosophila will tremendously enhance the ability to map the underlying neural circuits of any number of well-characterized Drosophila behaviors and thereby the understanding of how sensory information is translated into behavioral responses in this established model system with powerful molecular genetic advantages. In addition, it will be useful for eluciding the neural circuitry underlying Drosophila models of human medical conditions including neurodegenerative disease, addiction, and sleep.

Public health relevance
Adaptation to the fruit fly of a recently developed technique for identifying synaptic contact sites in the mouse will significantly enhance the ability to map neural circuits in the well-established fruit fly model system. This will facilitate our understandng of how the nervous system processes information and will have implications for numerous fly models of both normal nervous system function and human neurological conditions that involve neural circuits including sensory information processing, neurodegenerative disease, addiction, and sleep disorders.